MARC PROGRAM AT THE UNIVERSITY OF CALIFORNIA, IRVINE

Project Summary/Abstract
The MARC program at the University of California, Irvine (UCI) is a critical component of the School of
Biological Sciences Outreach, Research Training and Minority Science Programs (MSP) to promote broad
participation in the biomedical research workforce by increasing the number and academic excellence of
trainees from diverse backgrounds pursuing Ph.D. degrees and careers in biomedical research. The
MARC program has had a transformative institutional impact by preparing an unprecedented number of
undergraduates from underrepresented groups that have obtained research doctorate degrees in
biomedical sciences. MARC activities are designed to introduce trainees to biomedical research, improve
their academic preparedness and interest in biomedical research with an increasing self-direction. MARC
trainees are introduced to the excitement of generating new biomedical knowledge in a nurturing
environment that stimulates their critical thinking skills, self-confidence, self-identity as scientists, with
safety, rigorous research design and by conducting biomedical research responsibly, ethically, and with
integrity. Independent research conducted under the direction of faculty mentors at UCI and at partner
extramural sites serve as a core element to induce MARC scholars to pursue graduate school and
research-focused careers. Over 80 faculty with funded research programs and experience training
undergraduates (including individuals from groups underrepresented in the biomedical research
workforce) serve as preceptors of MARC scholars. The MARC research training elements are integrated
with the undergraduate curriculum and include, 1) individual career and academic advising, 2) a research
faculty seminar series, 3) a journal club to introduce scholars to critical reading of current biomedical
literature, 4) training in genomics, computational biology, statistics and methods to enhance
reproducibility, 5) training in responsible conduct of research, 6) independent research directed by faculty
mentors, 7) preparation to present oral presentations and posters at local and national conferences, 8)
training in scientific communications, 9) workshops on application to graduate school, and 10) individual
advice during the graduate school application process.

Public health relevance
Project Narrative The broad participation of undergraduates in biomedical research is critical to ensure that a diverse and highly trained workforce is available to assume leadership roles in the Nation's biomedical research enterprise, to address the need of improving the health of the people of the United States. This project provides extraordinary opportunities for undergraduates from diverse groups to be trained as the next generation of leaders in biomedical research.